Chemical approaches for generating blood-brain barrier-permeable antibody conjugates

1. ABSTRACT
The blood-brain barrier (BBB) restricts the influx of biomolecules from the vasculature to the brain
parenchyma. This attenuates exposure levels of the brain to systemically administered drugs, especially large-
size molecules such as antibodies. This issue also makes systemic treatment of glioblastoma (GBM), the most
devastating brain cancer, ineffective in most cases. Recent clinical studies have demonstrated that a
measurable number of GBM cells, in particular cells near the growing edge of the infiltrative tumor area, exist
behind an intact BBB. Collectively, the features of the BBB create a special challenge for effective treatment of
central nervous system (CNS) diseases, including brain cancer, using drugs that have proven efficacy in other
diseases.
Antibody-drug conjugates (ADCs) are an emerging drug class with prominent target specificity, durable
therapeutic efficacy, and high translatability in drug development. While promising, clinical benefits of ADCs in
the treatment of brain diseases, in particular GBM, remain unconfirmed. Unfortunately, recent interim analysis
in a Phase 3 study using the anti-EGFRvIII ADC Depatux-M (formerly called ABT-414) revealed no survival
benefit for patients with newly diagnosed GBM receiving this ADC. Thus, improvement in BBB penetrability for
ADCs is critically needed to advance this promising molecular format toward truly effective and safe systemic
therapy for CNS diseases.
We have developed novel ADC linker technologies, including: 1) branched linkers for site-specific and
simultaneous installation of two distinct molecules onto a single antibody and 2) enzymatically cleavable linkers
with exceptional circulation stability. Using these technologies, we have successfully constructed
homogeneous conjugates appended with peptides that facilitate traversing the BBB through receptor-mediated
transcytosis. One of the homogeneous peptide conjugates, as compared to a conventional heterogeneous
variant, showed greater accumulation into the brain parenchyma in healthy mice (2.7-fold) and orthotopic GBM
tumors in a xenograft mouse model (3.6-fold). Based on these findings, we hypothesize that homogeneous
conjugation of properly designed BBB-penetrating peptides with ADCs will be a promising approach for
systemic drug delivery to the brain. In this project, we will prepare a variety of BBB-penetrating peptides and
construct antibody conjugates with various conjugation modalities (linker attachment site, linker structure, and
stoichiometry of the peptides and payloads). All conjugates will be evaluated in vitro and in vivo for plasma
stability, receptor-mediated transcytosis efficiency, pharmacokinetics, biodistribution, tolerability, and
immunogenicity profiles. We will then evaluate a panel of BBB-permeable ADCs for tumor targeting efficiency
as well as therapeutic efficacy in cell line-based and patient-derived xenograft mouse models of orthotopic
GBM. We will also perform intravital fluorescence microscopy to evaluate kinetics and dynamics of
extravasation in both healthy and tumor-bearing mouse models.
Successful completion of this project will clarify the effect of the peptide structure and conjugation modality
on BBB penetrability of antibody conjugates as well as other drug properties. We also expect to identify rational
molecular design to unleash the full therapeutic potential of monoclonal antibodies and ADCs for brain
targeting, which may ultimately lead to novel drug development strategies toward a cure for difficult-to-treat
CNS diseases, such as GBM.

Public health relevance
Project Narrative Delivery of chemotherapeutic agents to the brain and brain tumor by systemic administration is a challenge because of the presence of the blood-brain barrier. We will explore novel antibody-based agents with improved blood-brain barrier penetration efficiency. We expect that completion of this study will lay the foundation for a new class of antibody agents for brain diseases including brain cancer with enhanced therapeutic efficacy and safety profiles.